Sex-specific differences in the tumor microenvironment alter glioblastoma growth

ABSTRACT
Sex differences are present in many pathological conditions, including a number of non-reproductive cancers.
These differences have been observed from an epidemiolocal perspective, and mechanistic studies have
revealed broad-ranging differences between sexes at the genetic, epigenetic, and cellular levels. In glioblastoma,
the most common primary malignant brain tumor, males present with disease nearly twice as often as females
and experience a poorer prognosis given the same standard-of-care treatments. As part of a current Program
Project Grant (P01 CA245705), we are focused on the cell-intrinsic and cell-extrinsic influences of sex
differences, as well as their interplay, in glioblastoma. These efforts have focused on multiple mechanisms,
including sex differences in the immune response, and found differences in the resident (microglial) and
infiltrating (namely myeloid-derived suppressor cell) immune populations. While these initial observations were
made using transplantable mouse glioblastoma models generated from genetically engineered or carcinogen-
induced mouse models and validated in human samples, these models are not strongly representative of the
human disease, as they lack key drivers, including mutation in the epidermal growth factor receptor (EGFR,
namely EGFRvIII). Using in vivo electroporation approaches supported by the NCI IMAT program, more
representative GBM models have been generated using Mosaic Analysis with Dual Recombinase (MADR) and
Genome Editing of Synthetic Target Arrays for Lineage Tracing (GESTALT) technologies that leverage
concomitant expression of key oncogenes such as EGFRvIII and deletion of key tumor suppressors such as
NF1 and p53. The overall objective of this revision application is to enhance our program through the use of
these more representative glioblastoma models to determine sex-specific immune response effects. In Aim 1,
we will determine how the glioblastoma immune microenvironment is arranged as a function of the biological sex
of the tumor. In parallel with these benchmarking studies, Aim 2 will take an unbiased, hypothesis-generating
approach to determine how the neural cell composition of the tumor microenvironment is generated as a function
of the biological sex of the developing glioblastoma. The MADR-GESTALT will be applied to wild-type mice, as
well as Project 3-specific mouse models (junctional adhesion molecule-A) and the four-core genotype model that
separates chromosomal and gonadal sex. The short-term goal of this application is to enhance Project 3 of our
Program Project Grant and provide this new model for all projects through Core C, which houses experimental
models. The long-term goal of this project is to leverage these more representative glioblastoma models for
future functional and mechanistic studies on sex differences in glioblastoma.

Public health relevance
PROJECT NARRATIVE Sex differences are present in glioblastoma (GBM), with males presenting with GBM more frequently than females and with a more aggressive disease. Many mouse models recapitulate these sex differences and have been leveraged for key observations of how the immune response contributes to GBM sex bias; however, many of these mouse models do not reflect key mutations observed in the human condition, and tumor models are often devoid of a complete set of sex chromosomes. The objective of this revision application is to integrate a more representative mouse model generated through the NCI IMAT Program into an ongoing P01 on sex differences in brain tumors with the goal of assessing the interaction between the immune response and changes in the tumor microenvironment using models that contain human mutations and intact sex chromosomes.